Guiding humans to create better labeled datasets for machine learning in biomedical research

ABSTRACT
The whole-slide images used in digital and computational pathology are stored in a tiled pyramidal format to
support smooth visualization. While there are a number of tools to read these images, there is a lack of
adequate tools available for easy and fast conversion of data to these tiled pyramidal formats. This limits the
ability of investigators who generate image analysis or other visualizations from viewing these using pathology
software tools. This has resulted in a disconnect between pathology software tools and general-purpose
software tools for data and image analysis like Numpy. In this proposal we will create optimized and easy-to-
use open-source programming interfaces that allow generation of tiled pyramidal images from a variety of
popular array and vector data formats. This will allow users to create arbitrarily large tiled pyramidal images
from Numpy, Zarr, and Dask arrays, and vector formats like Scalable Vector Graphics. Firstly, we will generate
and document a modular and general-purpose tiling interface for use in python. Second, we will implement
support for the most popular input and output formats. Third, we will focus on software engineering to ensure
that the software is maintainable and extensible by the research community. This includes documentation of
code and examples for use, implementing testing and code review, and packaging for package managers and
cloud-readiness. Altogether, this will allow investigators to better visualize the results of their analyses, and will
better integrate the now disconnected domains of digital pathology software and general purpose scientific and
data analysis software.

Public health relevance
PROJECT NARRATIVE There is currently a lack of tools for converting data to image formats that are compatible with digital pathology software. This has created a disconnect between popular general-purpose data analysis tools and digital pathology tools. This project will develop easy to use software that will allow the generation of compatible image formats from a variety of popular data formats including Numpy arrays. This will allow fast and simple generation of arbitrarily large image files and will improve data visualization and exploration for scientists.